Project 1: Overcoming Immune Exclusion in Microsatellite Stable Colorectal Cancer

PROJECT SUMMARY/ABSTRACT: Project 1
Although immune checkpoint inhibitors (ICIs) are highly effective in microsatellite unstable (MSI-H) colorectal
cancer (CRC), it has a limited clinical benefit for the 85% of CRCs that are classified as microsatellite stable
(MSS). This is due, at least in part, to a paucity of CD8+ T cells present in these tumors, which we define as
immune exclusion (IEX). The aim of Project 1 is to overcome IEX in MSS CRC; we define IEX as a paucity of
intratumoral CD8+ T cells. We recently discovered a four-gene signature associated with IEX and worse
progression-free survival in MSS CRC. We also discovered that two of the protein products of that signature,
DDR1 and TGFBi, are present in supermeres, a secreted amembranous nanoparticle we recently identified.
Levels of DDR1 and TGFBi are markedly increased in plasma-derived supermeres of CRC patients. In triple-
negative breast cancer, the shed ectodomain of DDR1, a collagen-activated receptor tyrosine kinase, binds to
the extracellular matrix so that CD8+ T cells are excluded from the tumor, and these T cells gain entry into the
tumor following administration of a neutralizing antibody to DDR1. Project 1 is participating in a clinical trial
introducing this neutralizing antibody to DDR1 (PRTH-101) along with the ICI pembrolizumab (Pembro). The
premise is that PRTH-101 will allow CD8 T cells to enter the tumor proper, and Pembro will overcome an immune
checkpoint to unleash the anti-tumor cytotoxic activity of these CD8+ T cells. Additional goals of this project are
to refine the IEX signature to determine markers of non-responsiveness to ICB therapy in MSI-H, as well as to
explore the diagnostic and therapeutic implication of DDR1 and TGFBi in supermeres.

Public health relevance
PROJECT NARRATIVE: Project 1 Microsatellite stable (MSS) colorectal cancer (CRC) is typically devoid of immune cell infiltration and therefore is unresponsive to immune checkpoint inhibitors (ICIs). We will use genetic and pharmacological approaches to interrogate immune exclusion-related proteins expressed in these cancers for the purpose of triggering immune infiltration and responsiveness to ICIs. Our goal is to understand the impact of immune exclusion-related proteins and target them for treating MSS CRC that makes up over 85% of CRC.